VASCULARIZED NERVE GRAFTS TO REPAIR FACIAL NERVE DEFECTS

The aim of this study is to compare the axonal regeneration and functional return of the facial nerve defects in the temporal bone (fallopian canal) by using vascularized and non-vascularized nerve grafts.